Biostatistics & Bioinformatics Shared Resource

PROJECT SUMMARY
BIOSTATISTICS & BIOINFORMATICS SHARED RESOURCE
The overarching goal of the Biostatistics & Bioinformatics Shared Resource (BBSR) is to provide comprehensive,
multidisciplinary data science expertise, with a focus on rigor and reproducible research, to Moffitt Members in
support of exceptional science and practice-changing investigator initiated clinical trials. BBSR consists of 16
faculty and 25 staff and provides diverse expertise in three focused areas: biostatistics, bioinformatics, and
informatics, with services spanning all facets of the scientific method from study design and power estimation to
data analysis and visualization. Further, BBSR closely collaborates with many other Moffitt Shared Resources
to ensure study power, proper handoffs and integration of data, and effective management of Member projects.
BBSR activities towards its goal are organized into four Specific Aims:
Aim 1: To provide study design, feasibility assessment, and sample size/power estimation for research projects,
protocols, and grant applications.
Aim 2: To provide biostatistical and bioinformatics analysis expertise for research projects, grants, and protocols.
Aim 3: To develop and support research enabling technologies, pipelines, and computational tools that facilitate
the timely and accurate completion of research projects in a reproducible manner.
Aim 4: To educate students, fellows, faculty members, and other investigators on study design, data collection,
and computational analysis aspects used in cancer research projects.
BBSR provides data science support (biostatistics, bioinformatics, informatics) using state-of-the-art methods
and technologies, with a focus on reproducible research, which result in better designed, powered, and
innovatively analyzed studies for Moffitt Members. In FY20, BBSR supported 118 Members across all five
Programs (CBE 17%, CE 20%, MM 31%, HOB 10 %, and IO 22%) with 72% of those Members holding peer
reviewed funding. This translated into support of 417 projects and 144 publications. This represents a 76%
increase in usage since FY16. BBSR also supported 203 grant proposal submissions by Members in FY20
alone. Importantly, BBSR contributions resulted in paradigm and practice shifting knowledge regarding the
prevention, treatment, and cure of cancer, as evidenced by 486 (60 high impact) publications since 2016. Future
initiatives of BBSR will provide integrated, cutting-edge services, platforms and analyses 1) in computational
immunology; 2) for single-cell spatial transcriptomics, proteomics, bisulfite-seq (scBS-seq), ATAC-seq, and TCR
and BCR repertoire; 3) of multiplexed immunofluorescence data; 4) of digital pathology; and 5) of neoantigen
identification. Furthermore, BBSR will continue developing novel approaches and visualization tools for data
integration and will expand its educational programs and services in managing data.